CRCNS: Dense longitudinal neuroimaging to evaluate learning in childhood

PROJECT SUMMARY
Understanding how learning occurs in early childhood has the potential to transform our understanding of
human learning and our approach to building intelligent machines, yet critical windows in early childhood
remain under-sampled and consequently provide little insight concerning learning. One fundamental and
long-standing question in human learning is the process by which neural specialization for visual letter and
digit processing emerges in the ﬁrst grade. This knowledge is critical for addressing public health concerns
related to reading and math literacy because ﬁrst-grade letter and digit knowledge are the strongest
predictors of future reading and math abilities, and children who fall behind in reading and math in elementary
school will likely experience medical and ﬁnancial instability as adults. This project employs a multi-level
approach to understanding learning in childhood that will support critical advancements in several disciplines,
including human and artiﬁcial learning, developmental and cognitive neuroscience, educational neuroscience,
neuroimaging methods, computer vision, and learning sciences broadly. The ﬁrst aim is to create and
distribute a large corpus of images from Sesame Street episodes annotated for educational content, such as
letters and digits, as well as for other common object categories. The image corpus will be the ﬁrst to capture
the visual statistics of child learners and can be used to train diﬀerent artiﬁcial learning architectures to better
understand human learning. The second aim is to collect, preprocess, and distribute a dense longitudinal MRI
dataset of brain structure and function sampled at multiple time points throughout the ﬁrst grade year. The
dense longitudinal MRI dataset will provide experimentally measured brain responses to images from the
Sesame Street corpus that will be of beneﬁt for understanding human learning and of appropriate scale for
constraining artiﬁcial learning architectures. The third aim is to evaluate the emergence of selective neural
processing for letters and digits as learning occurs throughout the ﬁrst year of schooling. This aim will
address an open question in human learning concerning the process by which neural specialization for letters
and digits emerges, namely the role of the motor system in emerging specialization. Understanding the time
course of changes in brain function and structure during early learning is critical for developing accurate
predictors of long-term life outcomes and for identifying sensitive windows of great plasticity to optimize
intervention timelines.

Public health relevance
PROJECT RELEVANCE This project will investigate brain changes that occur throughout the ﬁrst year of formal schooling, a year of foundational learning that has consequences for future academic attainment and other major life outcomes. Understanding the brain mechanisms that support emerging reading and mathematics throughout this ﬁrst year is crucial for developing biomarkers that can identify children at risk of future diﬃculties and may identify windows of great plasticity within the ﬁrst-grade year for optimal intervention.